A conversational agent to support remote care for individuals with substance use disorder

PROJECT SUMMARY
Substance use disorder (SUD) is a significant public health challenge, and it has been
estimated that its effects on healthcare, work productivity, and criminal justice costs the US over
$600 billion annually. Engagement with the clinical care team is critical to an individual’s path to
SUD recovery; however, limited capacity of and access to addiction treatment providers and
trained staff presents an even greater challenge when faced with an increasing demand for
care. Our proposed innovation, Suzy, is a novel and intelligent chatbot designed to provide
usable, engaging, on-demand follow-up support for individuals in long-term SUD recovery
guided by their clinical care team. In this Phase II work, we will evaluate effectiveness and
implementation of Suzy with primary care patients working closely with recovery coaches who
play a critical role in following up with and engaging patients in care. We will use a mixed
methods approach to evaluate effectiveness and implementation of Suzy following three specific
aims: In Aim 1, we will follow a human-centered design approach to build a fully functional
enhanced HIPAA-compliant chatbot. In Aim 2, we will conduct a single-group mixed methods
interventional study (Study 1) with patients to evaluate Suzy’s effectiveness and
implementation. In this aim, primary care patients will be enrolled with Suzy and complete
baseline, weekly, and endline assessments over the course of a 12-week intervention period. A
purposive sample of patients and their recovery coaches will participate in qualitative interviews
to collect perspectives on Suzy user experience and patient care. In Aim 3, we will assess
sustainability and conduct cost analyses (Study 2) for the system. Results of this Phase II
project will inform further development and adoption of a cost-effective, scalable solution built on
a community-based model of care to support continuing care for individuals beyond SUD
treatment and in pursuit of long-term health and wellbeing.

Public health relevance
PROJECT NARRATIVE Substance use disorder (SUD) is a major public health challenge in the United States that has been further exacerbated in recent years by the Covid-19 pandemic and social isolation, leading to a higher demand for treatment with limited provider capacity to meet the need. In this Phase II SBIR project, we will evaluate the effectiveness and implementation of Suzy, an innovative mobile- and web-based chatbot designed to provide engaging, scalable, on-demand follow-up support for primary care patients on the path to SUD recovery. Suzy will be developed with features that are evidence-based and will follow a community-based continuing care model with an interface designed with and for individuals who struggle with SUDs.